Synthetic organogenesis: new paradigms in reconstituting human organ development in vitro

PROJECT SUMMARY
Organogenesis is a process in which biochemical signals and mechanical cues transform embryonic germ layers
into organs during fetal development. Recent advances in stem cell biology created opportunities to differenti-
ating human pluripotent stem cells into expandable 3D tissues that contain many of the cellular and functional
characteristics of fetal organs, which we call organoids. They hold a tremendous potential to answer longstand-
ing questions of human development and one day to serve as a renewable source of patient-specific tissues.
However, organoids still only approximatively recapitulate organogenesis as they rely on spontaneous tissue
self-organization and the establishment of signaling gradients in unpredictable ways. Common protocols also
neglect the contribution of surrounding developing organs, especially from other germ layers, and because they
lack the vasculature, they are not scalable. This supplement proposal aims precisely to advance these gaps in the
current organoid paradigm; namely, by generating organoids from all three germ layers and by mimicking in
vitro angiogenesis to increase their scalability. We focus on the organogenesis of the gut tube, the embryonic
structure on which many adjacent organs form, and whose axial patterning strongly depends on the signaling
feedback between all three germ layers. We propose to employ microfluidics to generate precise signaling gra-
dients so to reproducibly mimic both the signaling and the morphogenesis of gut tube organogenesis in vitro.
We will generate carefully assembled components of the primitive gut tube comprising all three germ layers,
then expose them to signaling gradients in a highly controlled mechanical environment. Combined with live-
cell microscopy, CRISPR editing, and single cell transcriptomics, our multi-organoids will reveal a detailed hi-
erarchy of fate choices cells make from pluripotency to regionally segmented gut tube, and they will allow us to
make crucial connections between signaling, transcriptional regulation, and tissue morphogenesis. Our work
will shed light on the largely unknown regulatory mechanisms by which the three germ layers communicate to
generate complex and asymmetric patterns along the body axes.

Public health relevance
PROJECT NARRATIVE Understanding how cells in the embryo interpret complex signals and communicate between germ layers to create organs is one of the most challenging and important questions in biology. We propose to develop in vitro models of organ development by combining human stem cells, advanced tissue engineering, and genomic edit- ing techniques that will allow us to study detailed molecular mechanisms of organ formation in the developing gut tube across germ layers. The proposed work will significantly advance the current paradigms in organoid biology and will innovate technologies of recreating precise 3D morphogenesis of the gut tube.